Negative Symptoms, Cognition, and Functional Connectivity: Optimizing Transdiagnostic Relationships by Leveraging Advanced Techniques

Project Summary/Abstract
The current interventions for negative symptoms in psychotic disorders and mood disorders with psychosis,
particularly the experiential symptoms of reduced motivation and pleasure (MAP), are ineffective and wanting.
This is a critical area for improvement, given that MAP symptoms are highly prevalent and strongly associated
with disability and distress. However, we have a limited understanding of these symptoms' cognitive and neural
bases. Moreover, MAP symptoms are heterogeneous in their presence, presentation, severity, and origins
across individuals. Globally, traditional methods of assessing symptoms, cognition, and functional connectivity
(FC) do not capture important variability within and between individuals. Quantifying this variability is necessary
to understand the etiology and heterogeneity of MAP symptoms and develop effective interventions. Recently
developed approaches, ecological momentary assessment (EMA), repeatable mobile cognitive testing
(RMCT), naturalistic fMRI stimuli, and individual-specific functional connectivity (IS-FC) hold promise in
addressing this issue. The proposed project aims to integrate these methods to advance our understanding of
MAP symptoms' cognitive and neurobiological underpinnings in psychotic disorders and mood disorders with
psychosis to ultimately inform effective clinical interventions. The overarching aims of this proposal are to a)
investigate whether ecological momentary symptom assessment and repeatable mobile cognitive testing
reveal more robust relationships between MAP symptoms to cognition and FC compared to standard in-lab
clinical and cognitive assessments, b) examine whether IS-FC metrics lead to more robust relationships
between FC and MAP symptoms compared to group-based FC metrics while using FC acquired during the
processing of naturalistic stimuli, and c) assess to what extent these relationships are transdiagnostic across
psychotic disorders and mood disorders with psychosis. The principal goal is to bolster our current
understanding of the nature and etiology of experiential negative symptoms, which will, in turn, inform the
development of effective transdiagnostic interventions. This project will be realized through training goals about
gaining expertise on functional connectivity, negative symptoms across psychotic and mood disorders,
advanced statistical analyses, and developing rigor, reproducibility, and professional development skills.

Public health relevance
Project Narrative Negative symptoms, specifically experiential symptoms of reduced motivation and pleasure (MAP), are highly prevalent in psychotic disorders and mood disorders with psychosis and are strongly linked to disability and distress, yet treatments remain ineffective. This proposal seeks to employ four advanced methods— ecological momentary assessment (EMA), repeatable mobile cognitive testing (RMCT), naturalistic fMRI stimuli, and individual-specific functional connectivity (IS-FC)—to explore the connections between MAP symptoms with neurocognition and functional connectivity in psychotic disorders and mood disorders with psychosis. This project aims to further our understanding of the transdiagnostic cognitive and neurobiological bases of experiential negative symptoms, thereby informing the development of effective clinical interventions.